Spatiotemporal Profiling of the Tumor Immune Microenvironment

PROJECT SUMMARY
The tumor immune microenvironment (TIME) is a complex system, composed of immune and cancer cells,
tissues, and other biological components, that play an important role in the regulation and progression of
cancer. Traditional methods like flow cytometry and scRNA-seq have frequently failed to capture the complex
biology and mechanisms that drive immune cell interactions within this environment. However, advancements
in spatial transcriptomics have transformed our understanding of cellular heterogeneity, enabling the
identification of new cellular interactions and functional dynamics between different cell types and their
microenvironments that were previously elusive. Spatial transcriptomics builds upon the principles of single-cell
transcriptomics by preserving the spatial information of gene expression within tissue samples. This technology
allows researchers to study gene expression in the context of tissue architecture, providing a more complete
understanding of the cellular function and interactions between cells. Although this method preserves spatial
molecular information, it only provides a snapshot of gene expression at a single point in time, limiting our
ability to track molecular changes over time. To address this limitation, I propose developing a new method for
spatiotemporal monitoring of live tissue transcriptomics, allowing us to capture how immune cells interact and
respond to changes in the TIME during tumor development. In my predoctoral studies, I have engineered a
nanostraw array with an electrophoresis setup for RNA extraction from live cells with high viability, and
optimized a next-generation sequencing (NGS) spatial barcoding tool to preserve the spatial context of RNA
molecules post-extraction, allowing for longitudinal cell tracking. For the F99 phase, I will further refine the
nanostraw extraction setup and assess whether its integration with the NGS-based spatial barcoding platform
can preserve extracted RNA molecules between individual cells. To validate the live spatiotemporal mapping
technology's ability to monitor gene expression in the TIME over time, I will culture patient-derived tumor tissue
on nanostraws and track transcriptional changes in cancer and immune cells over 2-3 weeks, while also
examining spatial dynamics between these populations. This new technology will offer unprecedented insights
into cellular behavior, revealing spatial distributions, cell-cell interactions, and disease processes, with
transformative implications for cancer research. For the K00 phase, I will identify a combination of renowned
bioengineering and immunotherapy labs to explore the evolution and rearrangement of the TIME during
therapy and develop innovative tools at the intersection of synthetic and computational biology, integrating
single-cell genomics with both spatial and temporal resolution. Completion of this project will successfully
prepare me to launch an NIH-funded laboratory focused on designing novel sequencing platforms that bridge
space and time to study TIME dynamics and tumor evolution, for therapeutic targeting and personalized
medicine.

Public health relevance
PROJECT NARRATIVE The tumor immune microenvironment (TIME) is a complex system critical to cancer progression, but current methods fail to capture the full complexity of immune-cancer cell interactions and only provide single-time-point snapshots of gene expression, which limits our understanding of its biology and hinders the development of more effective therapies. During the F99 phase, I will develop a spatiotemporal technology, which combines a nanostraw array with a next-generation sequencing (NGS) spatial barcoding platform, to longitudinally profile gene expression with spatial resolution in the TIME, capturing cellular compositions, spatial distributions, and cell-cell interactions. For the K00 phase, I propose to study TIME during therapy by developing tools at the intersection of synthetic biology and computational biology, combining single-cell genomics with spatial and temporal resolution for accurately guiding treatment and predicting patient responses.